NF-kappaB and Mitochondrial Signals as Positive and Negative Regulators of Inflammation

See Abstract page
RELEVANCE (See instructions):
We will continue to study the role of mitochondrial DNA metabolism in NLRP3 inflammasome activation
and the effect of NRF2 on macrophage polarization. We will examine whether the pathogenesis of
osteoarthritis (OA) and Alzheimer’s disease (AD) in mice is accompanied by oxidized mitochondrial DNA
generation, its cleavage and export to the cytosol. We will also test the ability of CMPK2 and Fen1
inhibitors to attenuate NLRP3 inflammasome activation in OA, AD and other disease models.